Administrative Core

PROJECT SUMMARY/ABSTRACT
Administrative Core
The Administrative Core provides innovative scientific and organizational leadership in the coordination,
management, and oversight of Harvard University (HU) CFAR activities across its participating institutions. The
Administrative Core provides a structure to support the programmatic and fiscal needs of the CFAR in
catalyzing innovative, multidisciplinary HIV research, training the next generation of HIV investigators, and
promoting diversity, equity and inclusion throughout all aspects of the CFAR. The Administrative Core also
oversees the CFAR strategic planning process to ensure that it continues to serve the needs of the Harvard
HIV investigator community in advancing transformative research and providing leadership in global efforts to
prevent and treat HIV. The Administrative Core aims to:
1. Provide programmatic, administrative and fiscal support to CFAR Cores, Scientific Working Groups
and Scientific Programs, including their research, educational and training initiatives.
2. Implement new strategic initiatives, including programmatic and administrative support for CFAR
Steering Committees working on high priority areas.
3. Utilize multiple communications strategies to inform the HU CFAR community.
4. Oversee and direct strategic planning, policies and procedures.